Mechanisms and optimization of endosomal escape for delivery applications

PROJECT SUMMARY/ABSTRACT
Title: Mechanisms and optimization of endosomal escape for cell delivery applications
Controlled manipulation of cells through the precise intracellular delivery of biologically
active materials has been a long-term goal for probing of cellular mechanisms and therapeutic
interventions. Cellular delivery is however a problem that has not yet been solved. Most
techniques remain inefficient, are disruptive to cells and can be toxic. Furthermore, no single
approach works for all macromolecular cargo, across cell types, or in every context (e.g. cell
cultures vs in vivo). This problem is exacerbated by emerging biological applications
continually pushing the boundaries of required delivery efficiencies and versatility (e.g.
CRISPR-Cas9 technologies). This project aims to reveal fundamental mechanisms of how to
permeate cellular membranes, enabling precise control of the molecules that achieve this cell
permeation, and to develop new platforms for cellular delivery. Thus, the proposed studies will
significantly advance both understanding and solutions to the cell delivery problem.

Public health relevance
PROJECT NARRATIVE Title: Mechanisms and optimization of endosomal escape for cell delivery applications Reagents that can deliver proteins or nucleic acids inside live cells have the potential of revolutionizing the development of therapeutics for the treatment of human diseases. Currently, a major bottleneck in the field is that protein or nucleic acid therapeutics cannot penetrate cells efficiently. This project aims to solve this problem by developing reagents that make macromolecules cross membranes..